Regulation of selenium metabolism and stress response

PROJECT SUMMARY / ABSTRACT
Selenium is a trace element co-translationally incorporated as the 21st amino acid selenocysteine into
selenoproteins. Due to the unique properties of selenium, many selenoproteins have been implicated in
maintaining the reduction-oxidation homeostasis. The glutathione-dependent peroxidase GPX4 reduces lipid
peroxide into non-toxic lipid alcohol. It provides one of the primary cellular mechanisms to prevent ferroptosis, a
regulated cell death caused by the excessive accumulation of oxidatively damaged lipids. Using synthetic lethal
screens, we and others have recently discovered the low-density lipoprotein receptor-related protein LRP8
impacts cell sensitivity to ferroptosis by maintaining selenium levels. The decrease in cellular selenium leads to
ribosome collision, a premature termination of selenoprotein translation, and systematic changes in
transcriptome and proteome, indicating the importance of this essential micronutrition in maintaining cell
functions and viability. Yet, how selenium metabolism is regulated and how cells deal with low selenium remain
incompletely understood. This is mainly due to a lack of tools to consistently and efficiently deplete cellular
selenium, as removing selenium from cell culture supplements is complicated and expensive. To overcome this
critical gap in knowledge, we create a low selenium cell system with a 60% decrease in total selenium levels,
which mimics the effect of a selenium deficiency diet that causes several diseases in humans. In the next five
years, taking advantage of this cell system, we will investigate mechanisms underlying the regulation of selenium
metabolism and address two fundamental questions: 1. How does the regulation of selenium impact cell viability?
2. How do cells respond to low levels of selenium? Our research will not only advance our understanding of
selenium function and mechanisms governing cell response to stress but also will provide the basis for
developing new therapeutic tools to treat diseases associated with the dysregulation of selenium and its
metabolism. The techniques and experience acquired in this project will prepare our group for future research
exploring the molecular machinery of selenium-mediated maintenance of cellular homeostasis.

Public health relevance
PROJECT NARRATIVE The essential micronutrient selenium is co-translationally incorporated as the 21st amino acid selenocysteine into 25 selenoproteins. Many selenoproteins regulate redox homeostasis and are crucial for human health. Our research aims to understand the regulation of selenium metabolism and how cells respond to selenium deficiency.